Core C - High Spatial and Temporal Resolution Imaging Core

Project Summary – High Spatial and Temporal Resolution Imaging (HSTRI) Core (Core C)
The goal of the present proposal is to maintain and enhance a High Spatial and Temporal Resolution Imaging
Core (HSTRI) research core (Core C) that offers a wide array of state-of-the-art instruments enabling
visualization of cells and tissues samples pharmacologically or genetically labeled with fluorescent indicators.
With the assistance of expert staff and unrestricted access to these instruments, greatly enhanced the
competitiveness of Research Project Leaders (RPLs) in Phase I, and we will provide the same services to RPLs,
pipeline investigators, and Pilot Project leaders in Phase II. This facility is specifically designed to meet the needs
of our RPLs but will also enhance the overall capacity for biomedical research at the University of Nevada, Reno.
Core C will accomplish the following Specific Aims during Phase II of the COBRE: Specific Aim 1: To operate
and expand a facility providing state-of-the-art high spatial and temporal resolution imaging
methodologies for studying cellular structure, signaling pathways, and function in health and disease.
Recent advances in microscopy have produced a new generation of commercially available instruments that
enable biomedical researchers to investigate the relationships between structure and function in biological
systems with unprecedented spatial and temporal resolution. The main goal of this Specific Aim is to continue
making advanced imaging modalities available to COBRE investigators and to the larger UNR community of
researchers. Specific Aim 2: To continue advising, training, and informing investigators in the use of the
new technologies. Training users in the operation of HSTRI Core equipment and appropriate sample
preparation, as well as educating them about the scientific possibilities offered by these technologies, is crucial
to maximizing the Core’s impact on research and for achieving long-term self-sustainability. Core personnel will
continue to provide appropriate training and supervision of users, manage the logistical challenges associated
with accommodating multiple research projects, and offer workshops on novel microscopy and imaging
approaches. Specific Aim 3: To expand the userbase and devise an operational plan that will sustain the
long-term viability of the Core. Plans were already implemented during Phase I and will continue to be
developed to provide support for the Core after the end of the funded period through a business plan of revenues
that includes user fees and institutional support. As was the case for Phase I, HSTRI Core services will continue
to be offered to investigators directly associated with the COBRE (Research and Pipeline Project Leaders, and
Senior COBRE investigators) and non-COBRE investigators at times not reserved by COBRE investigators.
Notable in this latter context, many well-funded laboratories at UNR Med and UNR, including non-biological labs
in Engineering, have begun utilizing the infrastructure to incorporate high-resolution imaging methods in their
research and grant applications.

Public health relevance
Project Narrative – High Spatial and Temporal Resolution Imaging (HSTRI) Core (Core C) We propose to expand the services offered by the High Spatial and Temporal Resolution Imaging (HSTRI) Core established during Phase I COBRE with the goal of providing instrumentation and scientific expertise that will enable COBRE Project Leaders to perform crucial experiments that are not possible in their individual laboratories. With the assistance of expert staff and unrestricted access to these instruments, we expect the HSTRI Core to greatly enhance the competitiveness of Project Leaders in future grant applications and promote their recognition and contribution to their respective field at the international level, both of which will accelerate the pace of discovery. This facility is specifically designed to meet the needs of our Project Leaders but will also enhance the overall capacity for research by serving as a campus wide infrastructure to assist researchers at the University of Nevada, Reno, and the UNR School of Medicine.